Cutting-edge, Customized, and Comprehensive (CCC) HIV capacity building for Vietnam and Thailand

ABSTRACT
Women living with HIV (WLWH) in Vietnam face multifaceted vulnerabilities where HIV stigma and gender
disparities intersect with challenges stemming from a patriarchal, family-oriented culture. Leveraging evidence-
based interventions to address these critical gaps in healthcare for WLWH is crucial. This proposed
supplement, titled “Enhancing Family-Centered Interventions for Women with HIV/AIDS in Vietnam Through
Implementation Science” involves mentored implementation science research aimed at identifying and
adapting evidence-based, family-centered interventions tailored to the cultural and societal context, as well as
the specific needs of WLWH in Vietnam. This administrative supplement proposal builds upon our current
Cutting-edge, Customized, and Comprehensive (CCC) HIV Capacity Building Program for Vietnam and
Thailand (D43TW012489; 2024-2028), a collaboration among University of California, Los Angeles (UCLA),
Hanoi Medical University (HMU), and Chiang Mai University (CMU). Junior faculties/researchers at HMU who
possess enthusiastic research interests in implementation science and women’s health (Dr. Dinh Thanh Thuy
and Mr. Giang Trường Nguyễn) will serve as Co-Investigators of this mentored research. The supplement is
structured around three components with corresponding aims: 1) identifying existing family-centered
interventions for WLWH through a comprehensive scoping review and systematic evaluation by a Community
Advisory Board using the Hexagon Tool; 2) investigating the features and attributes of evidence-based
interventions that influence their acceptability among WLWH and their partners through conjoint analysis; and
3) adapting the most promising interventions for local health systems using World Café discussions to ensure
cultural congruence. This research initiative will yield crucial insights into evidence-based strategies that
empower WLWH and their families in Vietnam, enhancing their engagement with healthcare services and
improving health outcomes. Additionally, the project will significantly strengthen local research capacity by
providing practical, hands-on training in implementation science theoretical frameworks and methodologies to
junior researchers and graduate students at HMU. This training will equip them to lead future health
interventions and research, thereby enhancing the quality of healthcare provision for WLWH in Vietnam and
potentially in other similar contexts globally.

Public health relevance
PROJECT NARRATIVE This proposed administrative supplement aims to address the complex intersection of HIV stigma, gender disparity, and cultural vulnerabilities faced by women living with HIV/AIDS (WLHA) in Vietnam. Through mentored implementation science research, the project will facilitate selection and adaptation of evidence- based, family-centered interventions to improve health outcomes for WLHA. Additionally, comprehensive hands-on training and mentoring will equip junior researchers in Vietnam with the skills necessary to become future leaders in implementation science, ensuring local capacity to sustain and expand these critical health improvement efforts for WLHA.